Clinical Core

PROJECT SUMMARY/ABSTRACT: Clinical Core
The mission of the HU CFAR is to expand, promote, and facilitate collaborative, innovative, multidisciplinary HIV/AIDS research among its members to bring an end to the HIV epidemic. Critical to this mission is the Clinical Core, which provides essential resources to support and foster clinical and translational research among clinical, social, behavioral, and basic scientists. The primary goals of the Clinical Core are to facilitate access for investigators and prospective study participants to clinical research, to provide regulatory support to CFAR investigators’ human studies research, to facilitate storage and access of specimens and research data from people living with and without HIV, and to catalyze clinical and translational research at HU CFAR and through inter-CFAR collaborations. These efforts include close linkages to and communication with communities affected by HIV. Critically, the services supported by the CFAR Clinical Core are either not funded or are inadequately funded by other support mechanisms, and, thus, the value added by this Core has been immense. In the past 5 years, the Clinical Core has supported 47 NIH-funded investigators and 160 active NIH projects; importantly, 28% of the investigators were Early Career Investigators. During this time, there have been 105 users of the Clinical Core with over 306 documented instances of core services. Clinical Core resources were cited in 125 publications, including in high-impact journals such as Nature, Nature Medicine, Science, Cell, Immunity, and the New England Journal of Medicine. The impact of the Clinical Core extends well beyond Boston and Cambridge, by providing a link to multiple international collaborating sites, both in terms of facilitating access to clinical samples and through a series of innovative educational programs designed to enhance clinical research. While the mission of the Clinical Core remains to facilitate clinical and translational research, the Core continues to evolve and modify its programs to meet the emerging needs of investigators.